Centralization of Cancer Care: Implications for Access, Outcomes, and Disparities

Project Summary
In recent years, cancer treatment has dramatically shifted towards a centralized model of care,
whereby patients with cancer selectively receive complex treatment at regional referral centers, which
tend to be tertiary cancer centers. Centralization is associated with improved outcomes for the
patients who receive care at regional referral centers for a variety of reasons, including better
resources and personnel who treat high volumes of patients. However, the broader impact of
centralization on outcomes at the population level remains unknown. Of specific concern are the
patients who do not receive care at these centers, but instead continue to receive care at non-regional
referral centers, which generally treat lower volumes of patients. These “left behind” patients may
suffer poor outcomes due to decreased access to high-quality care. Moreover, to the degree these
patients represent traditionally underserved patients (i.e., sociodemographic groups that have long
experienced health disparities such as racial and ethnic minorities, low-income individuals, and rural
residents), the trend towards centralized cancer care may inadvertently widen disparities in outcomes,
worsening care for those patients left behind. The overall goal of this project is to critically examine
the impact of cancer treatment centralization at the population level, with a specific focus on whether
the trend toward centralization is inadvertently widening sociodemographic disparities in cancer
outcomes. We will use a mixed-methods approach as well as an innovative dataset linking cancer
registry and administrative data in two large states (New York and Pennsylvania) over an 11-year
period. We will focus on patients with the most prevalent (i.e., bladder, breast, colorectal, lung,
prostate) and lethal (i.e., brain, esophageal, liver, lung, pancreatic) cancers—these cancers frequently
require complex treatments and have improved outcomes at regional referral centers. In Aim 1, we
will determine the patient characteristics associated with not receiving care at a regional referral
center. In Aim 2, we will examine whether receipt of care at a regional referral center mediates the
relationship between being a traditionally underserved patient (racial/ethnic minority, low-income
individual, rural resident) and quality of care. In Aim 3, we will identify strategies to minimize cancer
disparities in the context of centralization through interviews with key stakeholders. This study is
important because it will provide hospitals, providers, and policymakers with actionable new data on
the ways centralization may be both helping and harming patients, leading to new strategies to
minimize health disparities with implications for interventions and policy changes at multiple levels.

Public health relevance
Project Narrative Health care delivery for patients with cancer has become increasingly centralized in regional referral centers over time. This proposal will examine the ways in which centralized cancer care may be both helping and harming patients, particularly those who may be less likely to receive care at regional referral centers (e.g., racial/ethnic minorities, low-income individuals, and rural residents). The results not only will provide new insight into how recent shifts in cancer delivery may have widened disparities in cancer outcomes, but also will provide strategies to improve outcomes for millions of cancer patients through improvements in the regional organization of cancer care.